A Network Perspective on the Neurodevelopment of Emotion Dysregulation in Adolescence: Insights into Depression and Anxiety

Project Summary
Adolescent depression and anxiety commonly co-occur, and this co-occurrence is associated with poorer health,
psychological, and social outcomes than either presentation in isolation. Yet, little is known about the potential
neural substrates driving the co-occurrence of depression and anxiety in adolescence. Thus, an essential next
step is to examine specific neural mechanisms underlying this co-occurrence to provide critical insights into
prevention and treatment targets. Although extant research in this area has identified disturbances in specific
brain regions, this approach is inherently limited, as the brain functions as a network. The examination of
disturbances in the organization of brain networks related to emerging, co-occurring depression and anxiety may
provide a more complete delineation of underlying etiological mechanisms. Moreover, the majority of research
in this area has used variable-centered approaches, which fail to reflect the vast heterogeneity in network
organization. Alternatively, person-centered approaches leverage the associations between individuals to
identify subgroups based on (within-group) convergence and (between-group) differences in network
organization. Identifying subgroups of individuals with similar network patterns allows us to examine whether
such subgroups display distinct profiles of depression and anxiety, a critical next step in advancing our etiological
and treatment models of depression and anxiety. These gaps in the literature could be addressed via the use of
complex, cutting-edge network analyses, specifically graph theory and Subgrouping-Group Iterative Multiple
Model Estimation. In line with NIMH’s Strategic Plan Objective 1.3.A, the objective of the proposed research
is to isolate disturbances in neural networks that are shared by emerging depression and anxiety (Aim 1) and
identify distinct subgroups of adolescents, based on patterns of underlying network connectivity, which may
display differing symptom profiles (Aim 2). We use a dimensional (vs. diagnostic group) approach to fully capture
the range of pathology, which is particularly relevant during adolescence, when pathology may still be emerging,
and thus not at the level for a full diagnosis. The proposed research will use archival data collected from a
community sample of adolescents (N=200). Functional magnetic resonance imaging (fMRI) data were collected
during an explicit emotion regulation task in which participants were instructed to either react naturally or utilize
cognitive reappraisal in response to negative and neutral stimuli. The ultimate goal of this research is to refine
etiological models of depression and anxiety in adolescence by identifying shared and unique network
mechanisms. The proposed F31 will allow the Applicant to gain expertise in two critical areas that are beyond
the scope of the standard graduate curriculum: (i) adolescent depression and its shared mechanisms with anxiety
and (ii) complex statistical analysis of brain networks. The institutional environment and mentorship team will
provide ample opportunities for the Applicant’s development towards an independent research career.

Public health relevance
Project Narrative Adolescent depression and anxiety frequently co-occur, and the burden of this co-occurrence is worse than either presentation in isolation, with greater health, social, and academic impairments and higher public health costs. The objective of this application is to utilize two advanced statistical analytic approaches to examining brain networks, graph theory and Subgrouping-Group Iterative Multiple Model Estimation (S-GIMME), to elucidate shared neural mechanisms and parse heterogeneity in such mechanisms by identifying profiles of depression, anxiety, and their co-occurrence. The proposed training and research plans are intended to further develop the applicant’s program of research on the neurobiology of emerging depression and anxiety and the advanced statistical analysis of brain networks.